Adolescent circadian misalignment: Mechanistic studies of sleep and light

PROJECT SUMMARY
Circadian clocks shift later (delay) with the progression of puberty; this shift contributes to late sleep onsets in
older adolescents. Early school start times, however, force teenagers awake earlier than their spontaneous
wake time and the opportunity for sleep shortens. Indeed, a majority of adolescents in the U.S. are chronically
sleep deprived, getting 1- 2 h less sleep than recommended. Also, many adolescents wake for school at the
“wrong” circadian time. Chronic circadian misalignment and sleep restriction are at their peak during late
adolescence, and are associated with morning daytime sleepiness, poor academic performance, conduct
problems, depressed mood, suicidal ideation, substance use, and obesity. Morning bright light exposure from
light boxes can shift rhythms earlier (phase advance) to facilitate earlier sleep onset, and reduce circadian
misalignment and the associated risks. We constructed the first phase response curve (PRC) to light for
adolescents and determined that the optimal time for bright light exposure to produce phase advances was ~1
h before habitual wake and light should be avoided around the time of habitual bedtime because it causes
rhythms to shift later (delay). Studies of adults, however, indicate that restricted sleep and exposure to
evening light due to late bedtimes – two classic features of older adolescent sleep – make morning bright light
less effective in producing advances. Our pilot data in adolescents mimic this finding, but also suggest that
staying awake late in normal household lighting and the subsequent sleep restriction before and during a 3-day
morning bright light regimen, can shift the system in the wrong direction (phase delay). The overarching goal of
this proposal is to examine the DOSE of sleep restriction and evening household light that prevents the desired
phase advance to morning bright light in adolescents aged 14-17 years. Study 1 proposes to construct a sleep
restriction with normal household evening light dose-response curve to determine the point at which morning
bright light begins to lose its effectiveness. Following a baseline week with 10-h sleep opportunities,
participants will keep the same wake time but be randomly assigned to one of 4 bedtimes which will be the
same or later than baseline to produce 4 levels of sleep restriction with evening light (0, 1.5, 3, or 4.5 h). After
2 nights, we will gradually shift the sleep schedule earlier for 3 nights, and participants will receive bright light
each morning. We hypothesize that the circadian system will advance with sufficient sleep, but with increasing
sleep restriction/evening light, circadian rhythms will not shift or will delay despite the phase advancing
morning bright light. Study 2 will test whether attenuating evening light exposure by wearing sunglasses
before bedtime during sleep restriction can facilitate phase advances. Study 2 will test the same 4 “doses” of
sleep restriction. The main outcome measures to build the dose-response curves will be phase shifts of the
central circadian clock marked by the dim light melatonin onset (DLMO) and total sleep time measured from
wrist actigraphy in the laboratory. Secondary outcomes include cognitive performance, sleepiness, and mood.

Public health relevance
PROJECT NARRATIVE This project will provide recommendations to health care providers, as well as adolescents and their parents to improve efficacy of circadian-based treatment strategies aimed to help youngsters fall asleep early, increase school-night sleep duration, and improve morning alertness. Enhancing these outcomes will likely improve learning capacity and problem-solving, as well as reduce the risk of depressed mood, obesity, automobile accidents, alcohol or drug use, and other risk-taking behavior.